Systems Genetics Analysis of Alzheimer's Disease-Related Sleep Loss and the Transition to Dementia

PROJECT SUMMARY
Our proposed research is expected to identify genetic factors that underlie disordered sleep associated with
Alzheimer's disease (AD), and determine if they are intervenable to stave off cognitive symptoms. Detection
and validation of these genes will promote possible treatments through discovery of new targets and biological
pathways that may aid in alleviating disease burden and improving quality of life in humans. The data
generated in this proposal will also be cross-checked with available datasets from human cohorts and
postmortem samples, such that advances in our current understanding of the networks and mechanisms in
mice can be understood in the context of human AD. We will leverage advanced mouse models to
identify
molecular and cellular mechanisms underlying the bidirectional relationship between AD pathology and
disruptions in sleep. In Aim 1, we will identify genes and molecular networks associated with sleep loss in a
large population of AD mice that better model human AD. In Aim 2, we will translate genes and networks
underlying variation in sleep loss to human AD cohorts. Finally, in Aim 3, we will validate genetic and
modifiable factors associated with sleep loss and dysfunction, and determine their effects on onset and
progression of memory deficits in powerful AD models.

Public health relevance
PROJECT NARRATIVE Sleep problems are common in Alzheimer's disease patients and are thought to influence disease severity and progression. The work proposed here seeks to identify genes that underlie an individual's risk for developing Alzheimer's-related loss of sleep using a well-characterized, genetically diverse mouse population that better models the complexity of human genetic diversity; traditional mouse models of Alzheimer's disease have provided substantial insights into possible mechanisms causing sleep loss in Alzheimer's disease. The results from the studies we propose will significantly extend current knowledge and have the potential to identify specific gene targets with the potential for translation to therapies for the elderly population suffering from various neurodegenerations.